Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
This Core Support Center Grant (P30) application requests continued support for an analytical chemistry
laboratory and administrative shared core infrastructure, and support for a pilot project core. The overall aim of
the Administrative Core is to provide a resource to facilitate collaborative research in the drug abuse area. This
includes assistance in study design and research proposals, including the services of a statistician, preparation
of manuscripts, IRB submissions, assistance in data analysis and reporting, grants management, and other
administrative needs common to research with human subjects. The vast experience of Drs Jones and
Benowitz is invaluable to early stage investigators in training and mentoring. A main function of the
Administrative Core is to promote and maintain collaborations that utilize the analytical chemistry provided by
the Research Support Core. This resource enhances and extends research possibilities of investigators
currently funded by NIH or other federal or nonfederal agencies to further our understanding of human
psychoactive drug use, abuse and addiction, its health consequences and its treatment management.